Deconvoluting CAR T cell heterogeneity to engineer durable antitumor protection

ABSTRACT
Chimeric antigen receptor (CAR) T cells are remarkably effective against advanced hematologic tumors,
mediating complete remission in >50% of patients. Yet they have limited success against solid tumors due to the
immunosuppressive tumor microenvironment (TME). To improve efficacy, CAR T cells can be “armored” with
growth factors, such as IL-2 and IL-15, to promote expansion and survival within the TME. Alternatively, “arming”
CAR T cells with inflammatory cytokines amplifies antitumor responses by activating host T cells. We recently
armored and armed CAR T cells with an IL-2 superkine (Super2) and tissue alarmin IL-33 (hereafter,
Super2+33). These cytokines act synergistically and, with multiple CAR constructs, to alter the TME to promote
regression of primary and metastatic solid tumors. However, the ability of CAR T cells to provide durable
antitumor immunity remains an open question. Analysis of two long-term survivors who received CD19-targeting
CAR T cells shows decade-long persistence of CAR T cells, leukemia regression, and loss of normal B cells.
Clinical responses are also positively associated with transcriptional features of stem cell memory T (TSCM) cells
in the manufactured CAR T-cell product. These data have spurred the field to optimize in-vitro manufacturing
conditions to increase memory T-cell potential within the CAR T-cell product. However, the in-vivo fate of
individual CAR T cells within a heterogenous CAR T cell population, such as each cell's ability to proliferate,
infiltrate tumors, kill, and differentiate into memory T cells, remains unknown. Moreover, it is unclear how CAR
engineering and host environmental factors impact the heterogeneity of CAR T cell effector and memory
responses. We will test the overall hypothesis that CAR T-cell heterogeneity can be deconvolved to understand
how individual T cell subsets behave in vivo and that principles gained through these analyses can help us
rationally engineer CAR T-cell populations that balance antitumor effector responses with generation of durably
protective antitumor CAR and host circulating (TCIRC) and widely distributed tissue resident (TRM) memory T cells.
This hypothesis will be tested in three aims. Aim 1 will use using dynamic lineage recording to deconvolve CAR
T cell heterogeneity to reveal individual differentiation trajectories and identify engineering strategies to program
CAR stem cell-like (TSCM) and TRM cell fates. Aim 2 will determine the respective requirements for host and CAR
T-cell memory. Aim 3 will identify the effect of tumor burden and neoadjuvant immune checkpoint blockade on
T-cell precursor subsets and states on CAR T cell differentiation. Successful completion of this study will advance
the development of durable adoptive CAR T-cell therapy for melanoma that results in globally distributed memory
T cells with optimal fitness and function.

Public health relevance
PROJECT NARRATIVE Adoptively transferred chimeric antigen receptor (CAR) T cells are remarkably effective against hematologic tumors with some long-term survivors exhibiting decade-long persistence of CAR T memory cells. The factors determining which CAR T cells transition into memory T cells are largely unknown, thereby hindering rational design of durable CAR T-cell therapies. Our studies will identify native and engineered factors that will allow CAR T cells and endogenous T cells to develop into broadly distributed memory T cells with the capacity to provide life-long protection against melanoma.